Early pathogenesis and diagnosis of Parkinsons Disease in peripheral tissues

Background: Parkinson's Disease (PD) is an enormous burden on the Veterans Health Administration (VHA)
and disease prevalence expected to double by 2030. Our understanding is very limited about the first two
decades of PD progression before diagnosis, called the prodromal period, because this stage involves vague
under-recognized symptoms such as non-motor disorders of the skin. Previous studies of skin tissue pathology
are limited but have implicated pathologic features associated with prodromal-stage PD, particularly neuronal
synuclein accumulation and aggregation. The knowledge gap about early PD and lack of tissue studies is a
major obstacle toward understanding pathogenesis, identifying subtypes, and ultimately disease-modifying
therapies.
Significance: This proposal will map the early pathologic features of prodromal PD in peripheral skin tissues
and link these pathologic features to clinical and genetic “big data” available at the VHA. Understanding the
timing and diagnostic utility of early peripheral pathology in PD is of high importance for the VA healthcare
system as the VA has an older average age, males are more likely to acquire the disease, PD is recognized as a
service-connected disease, and veterans with PD are more likely to rely solely on the VA for their health care
than veterans without PD.
Innovation: This proposal is innovative by creating curating a novel dataset measuring twenty years of
prodromal disorders in nationwide PD cases and 4:1 matched controls and cataloguing the presence of archival
biopsies spanning 1-20 years before PD diagnosis. In addition, this study for the first time integrates
histopathology, clinical data, and genetic data from the VA mega-biobank, called the Million Veterans Program
(MVP). Finally, this study is novel in comparing two leading biomarker assays, immunofluorescence and real-
time quaking induced conversion (RT-QuIC).
Specific Aims: 1) Determine the presence of neuronal synuclein accumulation and seeded synuclein
aggregation in skin preceding a diagnosis of PD and association with clinical disorders, 2) Determine the
association of genetic variants with prodromal clinical disorders and a cluster of disorders that co-segregate
with synuclein.
Methods: All PD patients and 4:1 matched controls are identified in the VA medical database (n=1.5 million)
and skin biopsies are identified before PD diagnosis or equivalent age controls. Tissue blocks will be collected
initially from the Portland pathology service and if needed scaled to tissue collaborators at Phoenix and Palo
Alto VAMC. Using immunofluorescent microscopy, we will measure neuronal α-synuclein and using RT-QuIC
we will measure synuclein seeded aggregation. Genome association analysis will be performed between
prodromal clinical disorders and variant allele frequencies from the MVP.
Next Steps: By understanding the earliest features of PD, this project can lead to targeted study of the earliest
causes of PD, relate complementary but oft unconnected data silos, and identify meaningful subtypes.

Public health relevance
Parkinson's disease is a growing burden for Veterans without a cure and usually without a known cause. For Veterans that have Parkinson's disease, we know the disease is usually widespread decades before diagnosis, including in the skin, and that catching the disease earlier could help us understand what causes the disease, how it spreads through the body, and how to find a cure. This project will map Parkinson's disease before diagnosis by using resources at the VA and a “big data” approach. The project will combine findings from biopsies and clinical care performed years before diagnosis with genetic studies in the Million Veteran Program. By combining these pieces of information, we hope to create a comprehensive description about how a Veteran's genetic background and symptoms relate to what's happening in his or her cells and tissues. By doing so we also hope to understand different types of Parkinson's disease. A better understanding of early Parkinson's disease should help in developing markers of disease and ultimately a cure.